Network of the National Library of Medicine Training Office

Project Summary
The Spencer S. Eccles Health Sciences Library at the University of Utah, as the Network of the National Library
of Medicine Training Office (NTO), will implement a 5-year grant to coordinate a national education program
that reliably delivers training for key NLM products and services. As a coordinator of a national program, the
NTO draws on the expertise of its personnel, strong track record of collaboration and growth, and innovative
methodology to expand the reach and impact of the NNLM through an education program that is responsive to
the needs of librarians, health professionals, the public health workforce, and consumers.
The NTO will lead the NNLM in the development and delivery of core curricula to support a highly-trained
workforce in biomedical and health information resources and data. NTO will also ensure a standard of high-
quality instruction and content through training and development of NNLM staff, class development and support
services, and evidence-based standards for accurate, current and accessible learning experiences. Through
collaboration with NWSO, NTO will improve access and findability of NNLM-generated education objects to
support NNLM members and others with open resources for reuse and distribution, enhancing the reach of these
products. NTO will cooperate with the NNLM Evaluation Center, RMLs, Offices, and Centers to evaluate the
effectiveness of the national training program and make regular improvements.
EHSL is the only library in the country to be awarded the contract for the NNLM Training Office (NTO) and is
well-known across the RMLs for planning, creating, sharing, delivering, coordinating, and evaluating an
instructional program and educational materials based on key NLM products and services for a variety of
audiences. Continuation of the NTO at the University of Utah means that the NTO will have the full support of
University of Utah's Center for Teaching and Learning Excellence and Teaching and Learning Technologies,
allowing the NTO to use resources created at the University for NNLM purposes, with appropriate attribution.